Biophysical basis for enzyme mediated deglycation in protein repair

Project Summary/Abstract
Organisms across all domains of life decorate their protein molecules with an incredible diversity of
chemical modifications. Modifications on proteins are critical for their function, affecting protein structure, stability,
and interaction partners. Many of the proteins and the enzymes that read, write, and erase these modifications
are closely tied to human diseases ranging from neurological disorders to cancer to type 2 diabetes. While these
proteins and pathways can be targets to treat these diseases, we lack a high-resolution, mechanistic
understanding of how the cell installs, recognizes, and leverages certain post-translational modifications,
specifically ubiquitination and spontaneous, non-enzymatic modifications. Our lab is working to understand how
protein-protein interactions dynamically regulate post-translational modifications to alter proteome landscape
and impact human disease.
Protein glycation is an understudied post-translational modification that arises when a sugar covalently
attaches to a primary amine. This process occurs spontaneously under normal physiological conditions and is a
bio-marker in aging and the development, or worsening, of diseases such as diabetes, Alzheimer's disease,
osteoarthritis, and atherosclerosis. Early glycation events are reversible and represent one of the few protein
repair mechanisms in the cell. Deglycation is mediated by an unusual “hybrid” kinase/deglycase called
Fructosamine-3-kinase (FN3K). FN3K facilitates the removal of protein-linked glycans by directly
phosphorylating the attached sugar and destabilizing the sugar-protein linkage. FN3K and FN3K homologs are
found in all branches of the tree of life. The glycation of intracellular proteins is not well studied, yet the
conservation of FN3K and FN3K-related proteins underscores an important biological role for these enzymes. In
this project, my lab will use a multidisciplinary approach, including techniques and expertise in structural biology,
enzymology, and systems biology, to address sharply focused mechanistic questions regarding FN3K-mediate
protein repair. We hypothesize that an improved mechanistic understanding of FN3K will reveal new biological
insight into this ancient repair process, and that we can leverage this insight to better diagnose and treat diseases
associated with elevated glycation. In order to distinguish our contributions from those of others, we will integrate
reductionist and global approaches to develop a deeper and more complete understanding of the regulation and
repair of glycated proteins. Over the five-year funding period, the goals of this project are to: (i) determine the
structural and biophysical basis for FN3K-mediated protein repair (ii) systematically characterize the binding
kinetics and enzymatic activity of FN3K and FN3K-RP on diverse substrates; (iii) identify sites-specific FN3K
deglycation sites and their potential cross-talk with other PTMs. The successful completion of this work will
establish the molecular mechanisms that govern the protein deglycation repair process and will ultimately provide
needed breakthroughs in biomedical research.

Public health relevance
Project Narrative Protein glycation is a spontaneous reaction that is linked to a multitude of human diseases. Cells harbor a “hybrid” kinase/deglycase enzyme, fructosamine-3-kinase, to repair glycated proteins, yet despite its biological importance, we have a poor mechanistic understanding of how this enzyme works. We will use a multidisciplinary approach that integrates structural biology, enzymology, and systems biology to develop a compressive mechanistic understanding of FN3K-mediated protein repair.